Impact of SARS-CoV-2 on the cerebrovasculature as a risk factor for VCID: Role of Wnt/beta-catenin

Abstract
COVID-19 increases the risk of vascular contributions to cognitive impairment and dementia (VCID). VCID is
one of the most prevalent forms of dementia, so the potential public health impact of the COVID-19 pandemic
on future VCID is substantial. However, the mechanisms by which COVID-19 modifies VCID are unknown.
Identifying mechanisms that regulate how prior COVID-19 influences the brain endothelial cell response to
vascular stress is important. Here, we provide preliminary evidence that COVID-19 decreases resistance to
VCID by weakening the blood-brain barrier (BBB). This is accompanied by cerebrovascular inflammation. This
grant will test the novel mechanism that SARS-CoV-2 infection accelerates VCID by suppressing
cerebrovascular Wnt/β-catenin signaling. In Aim 1, we determine how prior SARS-CoV-2 infection
influences BBB permeability and cognition upon subsequent vascular insult, by genetic and epigenetic
modification. In Aim 2 we use endothelial-targeted genetic interventions to assess the contribution of Wnt/β-
cat targets to resistance to post-infectious VCID. In Aim 3, we ask whether established post-infectious VCID
can be reversed by increasing cerebrovascular Wnt/β-catenin. These studies could lead to novel approaches
to identify individuals at high risk for VCID and novel potential therapeutic strategies to mitigate the impact of
prior infection on the development of dementia.

Public health relevance
Narrative COVID-19 is increasingly recognized as a risk factor for vascular contributions to cognitive impairment and dementia, VCID. The mechanisms by which COVID-19 promotes vascular dementia are unclear. Our proposed research using mechanistic mouse models will investigate how modifications to brain endothelial cells caused by SARS-CoV-2 infection can promote development of vascular dementia by destabilizing the blood-brain barrier. These studies will establish novel targetable mechanisms to prevent or treat vascular dementia after infection.